Mechanisms and Structures of Pseudomonas aeruginosa hibernating ribosomes

Pseudomonas aeruginosa is an opportunistic pathogen that causes persistent biofilm infections.
Biofilms are difficult to treat with antibiotics, in part, because biofilms contain heterogeneous
subpopulations of cells, including dormant bacteria in zones that are depleted in oxygen or nutrients.
The dormant bacteria are not sensitive to antibiotics that target active metabolism. When bacteria
enter dormancy, they undergo metabolic reprogramming to reduce energy expensive processes, but
preserve essential macromolecules, including ribosomes, which are maintained in an inactive state.
Signaling of bacterial growth arrest is mediated, in part, by the stringent response, which in turn
controls the expression and activity of dormancy factors. Accessory ribosomal factors that interact
directly with ribosomes in nutrient depleted cells include hibernation promoting factor (HPF) and
ribosome modulation factor (RMF). These factors bind ribosomes in the mRNA channel, block
translation, and protect the rRNA against degradation by ribonucleases. Recent evidence and our
preliminary studies suggest that RMF and HPF are not the sole factors required for ribosome
hibernation. Entry of ribosomes into a hibernating state is likely mediated by members of the G3E
family of GTPases, by ribosome silencing factor (RsfS), and by sequestration to the inner membrane
by YqjD-like membrane proteins. Therefore, in P. aeruginosa, signaling of entry into hibernation is
complex and requires yet uncharacterized accessory proteins. The goals of this work are to determine
the structure and mechanisms by which these hibernation factors bind ribosomes and induce
dormancy in P. aeruginosa. We will use a combination of in vivo approaches and structural studies to
identify interactions between accessory proteins and ribosomes. For these studies, we will: (i) use in
vivo protein-protein interaction approaches to identify the roles of the cell cycle and defined mutations
on interactions of hibernation factors with ribosomes. We will also characterize the physiological
responses of starved cells that are impaired in ribosome hibernation. (ii) We will use cryo-electron
microscopy and single particle analysis to determine the structures of these specialized hibernation
factors in complex with ribosomes at near atomic-level resolution. (iii) We will use support from
National Cryo-Electron Tomography Centers for in situ 3D studies of ribosome structure and
heterogeneity in starved P. aeruginosa cells. The results from this work will allow us to understand the
structures, cellular distribution, and heterogeneity of hibernating ribosomes at high resolution as they
occur in vivo. Combined, the structural and in vivo studies described here will provide models for
ribosome hibernation in P. aeruginosa and other ESKAPE pathogens, while setting the stage for
structure-based drug discovery to target dormant bacteria.

Public health relevance
Antibiotics that are used clinically target active bacterial metabolism but are not effective against dormant bacteria. Biofilms contain subpopulations of dormant bacteria, making biofilm infections difficult to eradicate with antibiotics. In this research, we will characterize the molecular mechanisms and structures of proteins that allow bacteria to enter dormancy and survive while dormant, in order to identify antimicrobial targets for dormant bacteria.